Mindfulness-based ecological momentary intervention for smoking cessation among cancer survivors

PROJECT SUMMARY/ABSTRACT
Continued tobacco use among cancer survivors is linked to an increased risk of lowered effectiveness of cancer
treatment, greater cancer-related mortality, developing a secondary primary cancer, worse quality of life, and
increased cancer treatment costs ($3.4 billion/year). Despite high quit rates at cancer diagnosis, more than half
of survivors who quit resume smoking shortly thereafter. Mindfulness-based interventions (MBIs) hold great
promise in enhancing smoking abstinence among cancer survivors given its emphasis on purposefully paying
attention to immediate experience, thereby reducing reactivity to smoking triggers. The current proposal
addresses significant gaps in the extant smoking cessation literature for cancer survivors, which include: (1) A
limited understanding of the role of dynamic relations between cancer-specific (e.g., fatigue, pain, fear of cancer
recurrence) and general smoking risk factors (e.g., negative affect) contributing to smoking relapse given the
known chronic high stress level among cancer survivors, (2) Lack of real-time cessation interventions using
portable mobile devices such as smartphones (i.e., mobile health [mHealth]), (3) Little attention given to cancer-
specific cessation barriers for cancer survivors (e.g., shame, guilt) and (4) Barriers to treatment accessibility
among existing MBIs due to the time-intensiveness and in-person format. To address these gaps, the objective
of this proposal is to develop a mindfulness-based ecological momentary intervention (mindEMI) that delivers
MBI content in real-time and in the real world where quitting smoking takes place, and, when an elevated level
Dr.
Yang’s long-term career goal is to develop and evaluate accessible and scalable mHealth smoking cessation
interventions for cancer prevention with expertise in real-time measurement of cognitive-affective constructs. As
such, training goals address tobacco use and cancer survivorship, mHealth and clinical trials methodology,
quantitative and qualitative methods, clinical delivery of MBIs, and professional development.
of cancer-specific smoking relapse risk is indicated through ecological momentary assessment (EMA).
There are three
specific aims. The K99 phase will take place at the Moffitt Cancer Center. The aims during the K99 phase include:
(1) To identify the most psychometrically sound EMA items for measuring negative affect, positive affect, and
state mindfulness and (2) to develop a mindEMI targeting cancer-specific smoking vulnerabilities through an
iterative multi-step process among cancer survivors who smoke. The R00 phase aims to conduct a 2-arm pilot
randomized controlled trial (RCT) among cancer survivors to test the feasibility and acceptability of the mindEMI
for smoking cessation. Feasibility of RCT procedures in preparation for a larger subsequent study will also be
examined. This proposal is highly innovative because the mindEMI will address a crucial gap in the literature by
targeting cancer-specific smoking vulnerabilities and deliver an MBI in real-time when relapse risk is high for
cancer survivors. This work will inform a future trial to fully test the efficacy of mindEMI and directly addresses
the NCI’s mission to conduct and support cancer research to promote longer and healthier lives.

Public health relevance
PROJECT NARRATIVE Continued tobacco use among cancer survivors is a cause of second primary cancers and increased overall mortality, thus, there is an urgent need to develop novel smoking cessation interventions that particularly target cancer-specific risk factors of smoking relapse in real-time given chronic levels of high stress and unique cessation barriers in this population. We propose to develop a mindfulness-based intervention for smoking cessation tailored for cancer survivors, that delivers intervention content via smartphone application in real-time when risk of smoking relapse is high. This project will result in a highly scalable and cost-effective intervention for cancer survivors ready to be tested in a large-scale clinical trial.